Metal Ion Transport by the Cation Diffusion Facilitator Family

We are requesting funds to support an undergraduate student researcher during the summer
months of 2022. In particular, Charlene Manipon is an undergraduate in the Biochemistry
program at New York University and she has recently joined the Stokes lab to pursue a project
suitable for an honors thesis associated with her Bachelor's degree. She is currently learning
about the background of the project and about the biophysical tools that we use to analyze
structure and function of YiiP, which is the main target of the parent grant. Although she is only
able to work limited hours during the school year, this supplement will allow her to work full time
on this project over the summer. In addition, she will participate in programmatic activities
associated with the Summer Program for Undergraduate Researchers, which is run annually by
the Vilcek Graduate Institute of Biomolecular Sciences, including career-building seminars,
social events and attendance of the Leadership Alliance National Symposium where she will
present her work. As a member of the Stokes lab, she will also attend group meetings and
Work-in-Progress seminars associated with our graduate program in Biochemistry and
Molecular Biophysics as well as with the Ion Channels and Transporters in Immunology. The
project will focus on allosteric control of zinc transport by the cation diffusion facilitator YiiP,
which is consistent with the aims of the parent grant. In particular, she will use analytical
methods such as microscale thermophoresis, atomic absorption spectroscopy, solid supported
membrane electrophysiology and fluorimetry to assess zinc binding and transport activity of a
variety of mutants. These studies will be designed to understand roles of the three distinct zinc
binding sites either in stabilizing the structure of the homodimer or in eliciting allosteric changes
associated with transport.

Public health relevance
Our goal is to understand the mechanism by which the protein called YiiP transports zinc across biological membranes. The current application requests funds to support an undergraduate student to work on this project during the summer. This activity will promote the career development of this student as well as forwarding the specific aims of the parent grant.